8th International Conference on Stem Cell Engineering 2021

Project Summary Stem Cell Engineering aids in the development and acceleration of biomedical technologies. These technologies enable scientists and engineers to create regenerative therapeutics and engineer tissue. However, several challenges remain before many of these technologies can be utilized in industry to create consumer products. For instance, there exist gaps in fundamental knowledge regarding our understanding of processes such as morphogenesis. Additionally, as these are complex and sophisticated systems, equally sophisticated computational tools and models are required to analyze data. Thus, this field is inherently multidisciplinary, requiring the expertise of scientists who specialize in fundamental science, mathematicians who specialize in modelling and computational methods, and engineers which have experience with designing systems and optimizing processes. In response to this need, we have designed the 8th International Conference on Stem Cell Engineering 2021 taking place on July 8-10, 2021 in Boston, MA. The technologies presented at the conference will allows for the assessment of the effectiveness and outcomes of new biologics, processes, and procedures. The conference will integrate physical and engineering science with life sciences to advance basic research and medical care. Any NIH funding received will be used to increase the attendance of graduate students and early career researchers from underrepresented groups in science and engineering.

Public health relevance
Project Narrative The American Institute of Chemical Engineers (AIChE) will host the the 8th International Conference on Stem Cell Engineering 2021 taking place on July 8-10, 2021 in Boston, MA. The conference will be chaired by Mo Ebrahimkhani from the University of Pittsburgh and Omer Yilmaz from MIT, and will bring together leaders and trainees from cutting edge fields of stem cell engineering to develop the next- generation of stem cell technologies.